Temperature and metabolic compensation mechanisms in a circadian clock system

Project Summary/Abstract
Circadian clocks are intracellular enzymatic systems that provide a biochemical
representation of local time with profound consequences to health across diverse
organisms. Unlike most enzymes, biological clocks need to be insensitive to a range
of physiological temperatures and cellular energy levels so that organisms can
anticipate dawn and dusk reliably. However, the mechanisms by which circadian
clocks in any organism achieve insensitivity to temperature (i.e., temperature
compensation) and cellular energy levels (i.e., metabolic compensation) are far from
understood. Therefore, the overall vision of the LiWang lab for the next five years is to
elucidate the mechanisms of temperature compensation and metabolic
compensation in the circadian clock of cyanobacteria. Over the past 20 years, we
have made many impactful discoveries on mechanism of the cyanobacterial clock
and developed innovative methodologies and tools along the way. Thus, we are very
well positioned to succeed at filling critical gaps in knowledge in the field of
biological timekeeping. A major expected outcome of the work proposed here is a
detailed cause-and-effect model linking clock protein behavior and interactions to
temperature and metabolic compensation phenotypes in vivo.

Public health relevance
Project Narrative Circadian clocks provide an accurate internal representation of local time under a range of different physiological temperatures and cellular energy levels. However, the molecular mechanisms by which clocks compensate for such variations remain experimentally unresolved in any organism. Thus, the overall goal of this application is to fill these fundamentally important knowledge gaps and thereby significantly advance the field of chronobiology with a lasting impact.